A cloud-based learning module to analyze ATAC-seq and single cell ATAC-seq data

Abstract
The recent surge in genomic datasets can be attributed to advancements in genomic methodologies and the
availability of user-friendly kits, enabling genome-wide research across a diverse array of scientific disciplines.
These datasets harbor invaluable information, facilitating groundbreaking conclusions. Among these
methodologies, ChIP-seq to measure the chromatin occupancy of proteins has been a staple for many
researchers. CUT&RUN and CUT&Tag are two new methods measuring protein occupancy and require their
own bioinformatic considerations. These technologies have transformed our understanding of TF-mediated
gene regulation and the responsiveness of chromatin modifications. Despite the recognized value of these
data, the analysis often becomes a bottleneck due to the need for bioinformatic expertise and specific
computational resources. We will address these challenges and aid researchers in integrating chromatin
occupancy data with chromatin accessibility (ATAC-seq) and gene expression (RNA-seq) taught in other
NIH/NIGMS Sandbox modules. Therefore, we propose the development of cloud-based training focused on
Chromatin Occupancy by Next-Generation Sequencing, including ChIP-seq, CUT&RUN, and CUT&Tag. By
integrating these with other Sandbox modules (ATAC-seq and RNA-seq), users will learn how to perform basic
processing steps as well as critical downstream analyses. Our approach will use interactive lessons in Jupyter
notebooks that follow an example analysis of p63, H3K27ac in relation to the BAF complex. This module
targets a broad audience, including students, postdocs, INBRE scholars, and researchers with minimal or no
programming background. The project leaders, who are experienced in teaching and using these methods, are
uniquely qualified to develop this training module. Through this initiative, we aim to democratize access to
bioinformatics training, facilitating the analysis of chromatin occupancy genome-wide.

Public health relevance
Narrative Biomedical research produces vast quantities of raw data that require analysis with suitable tools and interpretation to draw meaningful conclusions. The self-learning training module we propose aims to facilitate the analysis of extensive genomic datasets in a cloud environment, utilizing standardized tools without the necessity of local server downloads. This approach obviates the need for establishing a local IT infrastructure to handle large-scale data analysis, thereby democratizing access to data and resources across all institutions.